Mechanistic Target of Rapamycin (MTOR) in human and murine cryptococcosis

PROJECT SUMMARY/ABSTRACT
Cryptococcus (Cn) species have a global impact on human health as an environmental, opportunistic fungal
pathogen that most commonly presents as pulmonary disease or meningoencephalitis (CM) causing an
estimated 180,000 deaths annually in a range of patient populations. Despite knowing that T-cells are required
for immune protection, little is known about the molecular mechanisms driving susceptibility to cryptococcosis.
Our long-term goal is to identify genetic and immunological defects leading to susceptibility to Cn to inform
pathobiology and personalized care. To address this goal, whole exome sequencing was performed on a
cohort of previously healthy patients without known immunosuppression to identifying rare alleles associated
with cryptococcosis and predicted to have deleterious functional consequences. For the first time, gene
enrichment pathway analysis identified MTOR signaling deficits as enriched in this population. The goal of this
proposal is to determine whether identified MTOR variants cause dysfunction in MTOR signaling associated
with increased susceptibility to cryptococcal disease. Our central hypothesis is that MTOR deficiency
predisposes patients to cryptococcosis and suggests functional MTOR signaling is required to clear Cn. This
will be accomplished by: (Aim 1) Characterizing the immunologic consequence of MTOR deficiency on
susceptibility to Cn using established murine models of cryptococcosis; and (Aim 2) Determining how patient
MTOR variants alter cell signaling and function in patient lymphocytes. The results from this proposal will begin
to elucidate for the first time mechanistically how human genetic variants in a single gene (MTOR) are
associated with specific susceptibility to cryptococcosis in previously healthy individuals with no known
immunologic defects. Thus, these results will provide novel insights into human disease susceptibility to Cn
and reveal the protective immune responses affected by MTOR deficiency. Ultimately, expanding our definition
for who is at risk for cryptococcosis and suggesting improved treatment opportunities for cryptococcosis
patients identified to have aberrant MTOR signaling through pharmacologic modulation of cell-specific
immunity. The applicants career goal is to become an independent scientist in the field of fungal immunology
with a focus on understanding the mechanism by which specific host genetic defects lead to susceptibility of
previously healthy patients to cryptococcosis. To meet this goal, the applicant will begin the process of
transition to an independent scientist by beginning to apply for tenure-track faculty positions in fall 2024 cycle.
Further, the applicant proposes a career development plan that will allow her to gain more experience in host
genetic susceptibility/fungal immunology, grant writing, and leadership skills through practical experience,
formal course work, and mentoring. Highly accomplished collaborators specialized in similar areas as the
proposed research project will mentor the applicants career development and provide expertise on different
aspects of the project.

Public health relevance
Public Health Relevance Statement Cryptococcus species have a global impact on human health as an environmental, opportunistic fungal pathogen that most commonly presents as pulmonary disease or meningoencephalitis causing an estimated 180,000 deaths annually. Understanding human genetic and immunologic factors underlying susceptibility to cryptococcal disease would improve patient outcomes and identify additional at-risk populations. For the first time, we have identified MTOR signaling pathway defects enriched in cryptococcosis patients, therefore this project seeks to: 1) Characterize the immunologic consequence of MTOR deficiency on disease using established murine models of cryptococcosis; and 2) Determine how patient MTOR variants alter cell signaling and function in patient cells.